Pain in community-based older African American Adults: The Jackson Heart Study

Chronic pain affects over 100 million American adults, with an estimated cost of $560-635 billion annually, yet
this major burden is relatively understudied in African Americans (AAs). Older adults are at increased risk of
having multiple painful conditions and are living longer with the negative impacts of chronic pain. Chronic pain,
regardless of anatomy or diagnosis involved (e.g., back pain, migraine), is the leading cause of disability
worldwide. Limited insights into whether common mechanisms underlie all pain conditions, regardless of
diagnosis, has contributed to inadequate pain management options. Health care providers who treat one pain
condition (e.g., joint pain) typically do not manage symptoms in other parts of the body (e.g., abdominal pain),
and patients are often referred from one specialist to another. Studying commonalities of various chronic
overlapping pain conditions (COPC) in community-based cohorts unselected for pain conditions can provide
novel insights into causes and consequences of chronic pain as a disease itself. For example, neurophysiologic
alterations in pain processing such as pain sensitization (assessing ascending pain pathways) and conditioned
pain modulation (CPM) (assessing descending pain modulation) may be common mechanisms underlying all
chronic pain. Such knowledge would spur development of novel pain management approaches for all types of
pain regardless of anatomy or diagnosis involved. Despite the substantial public health burden of chronic pain,
little is known about the epidemiology and evolution of COPC in older AA adults, nor of the impact of COPC on
physical or psychosocial function, risk of nursing home admission, and mortality in older AAs. We propose to
evaluate chronic pain in the upcoming study visit of a thoroughly-characterized community-based older AA cohort
unselected for any pain complaints, the Jackson Heart Study (JHS) (N~2540, two-thirds ≥age 65). We aim to
understand the epidemiology of COPC, regardless of anatomy or diagnosis involved, the evolution of COPC
over time, neurophysiologic alterations in pain processing, healthy lifestyle factors and psychosocial factors as
risk factors for COPC, and consequences of COPC and altered pain processing in older adults. We propose
acquiring objective quantitative sensory testing (QST) measures of pain sensitization and CPM, which are
associated with pain severity in experimental settings. Whether QST-assessed neurophysiologic alterations may
be common underlying risk factors for all forms of chronic pain, and for poor physical and psychosocial
functioning, institutionalization, and mortality in a community-based cohort of older AAs unselected for pain is
unknown. We will collect data regarding a multitude of chronic pain conditions, QST, healthy lifestyle factors,
physical and psychosocial function, and nursing home admissions during the next planned study visit, as well as
two follow-up assessments to obtain longitudinal data, and leverage the ongoing JHS surveillance of mortality.
Our work will address several knowledge gaps, and insights gained may ultimately facilitate new preventive and
therapeutic approaches to relieving chronic pain and its consequences, regardless of underlying diagnosis.

Public health relevance
PROJECT NARRATIVE Chronic pain is a leading cause of disability in the US and globally, especially among older adults, yet management options are limited and fundamental knowledge regarding causes and consequences of chronic overlapping pain conditions is lacking. We propose an inter-disciplinary study of chronic overlapping pain conditions in older African American adults who have been understudied in this regard, with a focus on neurophysiologic alterations, healthy lifestyle factors and psychosocial factors as underlying risk factors, and the impact of chronic overlapping pain conditions and neurophysiologic alterations in pain processing on physical and psychosocial function, ability to live independently, and mortality risk. The proposed work will bring new insights into chronic pain as a condition itself regardless of anatomic location of pain, with an aim to help the millions suffering from chronic pain.